Institutional Career Development Core

ABSTRACT
The proposed NIDCR KL2 application is to provide support for generating innovative translational science and
questions that will lead to a mentored K series grant award. With the strong support of my mentoring team
alongside robust institutional foundations from both Children’s Hospital of Philadelphia and the University of
Pennsylvania Institute for Translational Medicine and Therapeutics, this project for career development will
advance our scientific knowledge of craniofacial development in neuroscience and tooth mineralization.
Tooth enamel and neuronal development are both highly complex and integrated systems that occur at similar
time points during fetal growth. Unfortunately, many neurological disorders have limited biomarkers for identifying
the presence or severity prior to preventative strategies or therapeutic interventions. Recently, evidence
suggests that genetic, epigenetic, or environmental changes affecting enamel formation may reflect alterations
in behavior. It is also common that among the craniofacial disorders, both neurons and ameloblasts (enamel
cells) exhibit similar dysregulated patterns in vesicle transport and membrane turnover, though details of these
pathways have not been well investigated. These findings, therefore, hold a fascinating promise that tooth
enamel formation can be used as a biomarker for altered neurodevelopment through a common vesicle transport
mechanism affecting membrane turnover in the ameloblasts and neurons.
The TBC1 Domain-Containing Kinase (TBCK) syndrome is a rare craniofacial disorder that is characterized by
its spectrum of neurogenetic phenotypes, ranging from developmental delay, low muscle tone, coarse facial
features, and encephalopathy with altered periventricular white matter. In addition to the neurological deficits of
tbck mice mimicking the human phenotypes, recent findings have demonstrated a tooth enamel phenotype in
the tbck heterozygous knockout mice, indicating this mouse to be an excellent model for understanding the link
between these two tissue types and enamel as a biomarker for neurologic development. We therefore propose
to investigate the hypothesis that vesicle transport, specifically the PI3K-Akt signaling pathway, is disrupted in
teeth (as it is in neurons), such that the tooth enamel reflects aberrant neuronal development observed in the
mice and patients lacking TBCK. This hypothesis will be tested with the following specific aims:
Aim 1: Characterize the tooth phenotypes of both patients and mice with deficiencies in the Tbck gene.
This aim will test whether humans exhibit similar enamel phenotypes to those of tbck-/- mice. Aim 2: Determine
whether aberrant vesicle transport via PI3K-Akt signaling occurs in the enamel organ of mice deficient
in Tbck. This aim will test whether disrupted enamel formation is due to PI3k-Akt in the absence of tbck.
Completion of this project will provide an excellent foundation for future translational work in the crossover of
tooth and neurological development and will direct our understanding of the mechanistic underpinnings that drive
the dynamic intracellular processes that regulate vesicle transport.

Public health relevance
PROJECT NARRATIVE The proposed research will support tooth enamel as a biomarker for neurological development and provide a mechanistic link between neuronal and tooth enamel development. These have important implications for understanding the early identification, severity, and outcomes of patients with neurological syndromes and behavioral disorders. Future clinical applications be applied by performing non-invasive collection of exfoliated teeth to determine important neurological and behavioral risk factors in children with and without craniofacial disorders.